Project 4: Human studies to identify genes and characterize risk pathways involved in alcohol related outcomes

Project 4 of the VCU Alcohol Research Center uses human data to accomplish three complementary goals: (1)
advance discovery of genes involved in alcohol-related outcomes using multivariate genomic techniques, (2)
characterize the risk associated with identified variants in longitudinal samples to understand the pathways of
risk associated with identified variants, across development, and in conjunction with the environment, and (3)
create synergistic connections between model organism and human studies to advance our understanding of
how genetic influences impact alcohol-related outcomes. Each of these areas represent critical steps in using
genetic data to improve prevention, intervention, and treatment for alcohol use disorders (AUDs); results from
the previous cycle have already been used to successfully fund a spin-off project that involves building a
tailored prevention program incorporating genetic and environmental risk information. The next phase of
Project 4 is a direct extension of the successful strategy used in the previous cycle, expanded to include new
samples and statistical techniques to further advance discovery. The aims of Project 4 are to (Aim 1) apply
multivariate genomic methods to capitalize on genetic sharing between alcohol use phenotypes and other
psychiatric and behavioral traits to boost power to detect common variants associated with alcohol use
outcomes, and to characterize the pathways by which genetic variants operate. Bioinformatic characterization
of these identified genetic variant results through the Data Analysis, Integration and Resource Sharing (DAIRS)
Component, and in collaboration with Project 5, will help elucidate underlying biological risk pathways. We will
then apply results from these multivariate analyses to five complementary longitudinal datasets, consisting of
both population-based and high-risk samples, in order to (Aim 2a): map the behavioral phenotypes associated
with the genetic risk scores identified in Aim 1 from adolescence to mid-life; (Aim 2b) test for pathways of risk
across ancestral genetic groups and both sexes to ensure consistency of results; and (Aim 2c) integrate
genetic with environmental risk information to improve clinical prediction. Finally, Aim 3 establishes a
bidirectional pipeline for translation of human and model organism results, creating prioritized gene lists for
further interrogation by the model organism projects, and conducting gene- and locus-based tests for genes
and systems emerging from model organism projects in our longitudinal phenotype datasets, to characterize
the human behavioral outcomes associated with implicated genes. This will allow us to better understand the
effect of these genes in the human system and on the alcohol outcomes that are ultimately of interest.